Hypertension, antihypertensive treatment, and uterine fibroid diagnosis in an integrated healthcare system

PROJECT SUMMARY
This proposed four-year plan will support Susanna Mitro, PhD, MPH, in her transition to becoming an
independent investigator. Dr. Mitro’s long-term goal is to elucidate complex interrelationships between
cardiovascular health and benign gynecologic disease over the life course, using advanced statistical methods
in electronic health records data. Approximately 20-50% of women develop clinically significant uterine fibroids,
which can cause severe symptoms including heavy bleeding, pain, and fatigue. There are few non-invasive,
non-hormonal treatment options for fibroids, in part because the causes of fibroids are largely unknown.
Preliminary evidence suggests a link between elevated blood pressure and fibroid development, with the renin-
angiotensin system providing a potential mechanism, but additional prospective epidemiologic research is
needed. The proposed research will clarify associations between blood pressure, antihypertensive medication
use, and fibroid diagnosis, and will test renin-angiotensin system signaling as a potential mechanism linking
blood pressure and fibroid development. Specifically, Dr. Mitro will use an electronic health record-based
cohort of women aged 18-55 to: quantify prospective associations between blood pressure trajectories and
hypertension onset with fibroid diagnosis (Aim 1); estimate the causal effect of angiotensin-converting enzyme
inhibitor versus thiazide diuretic treatment on fibroid diagnosis, using target trial emulation methods (Aim 2);
and develop and validate a clinical fibroid severity model, enabling a future focus on clinically significant
fibroids beginning at diagnosis (Aim 3). Findings have strong potential to expand understanding of fibroid
etiology, leading to new treatment or prevention strategies. The proposal includes mentored and applied
training in 1) pharmacoepidemiology methods; 2) use of health systems data to study benign gynecologic
disease; 3) women’s cardiovascular epidemiology; and 4) professional skills, including grant-writing and
responsible conduct of research. Trainings include coursework, seminars, conferences, and one-on-one and
group mentorship from an exceptional team with complementary clinical, biostatistical, and epidemiologic
expertise. Dr. Mitro’s proposed research and training benefits greatly from access to the outstanding resources
available at her institution, Kaiser Permanente Northern California, an integrated healthcare delivery system
serving a diverse population of over 4 million members whose complete medical experiences are captured in
the electronic health record. Dr. Mitro has a strong foundation of training in epidemiology and biostatistics and
prior research experiences in cardiometabolic health and fibroid treatment effectiveness. This Career
Development Award will equip her with the knowledge, skills, and preliminary data to develop competitive R01
proposals and to establish a successful research program focused on assessing longitudinal interrelationships
between benign gynecologic disease and cardiovascular health, with long-term potential to clarify the
development of both benign gynecologic disease and cardiovascular risk factors in women.

Public health relevance
PROJECT NARRATIVE Up to half of women may develop clinically significant uterine fibroids, benign tumors with severe symptoms; there are no prevention strategies, and causes are poorly understood. This study assesses associations between blood pressure, specific antihypertensive medication use, and risk of fibroids using electronic health record data in an integrated healthcare system. Findings have strong potential to expand understanding of fibroid etiology, which is needed to develop new treatment or prevention strategies.